Evaluating mechanisms of sex differences in environmentally-induced metabolic diseases

Mechanistic studies pertaining to sex-based differences in metabolic syndrome (MetS) are currently insufficient
to explain and prevent the higher prevalence of certain MetS symptoms in women versus men and
higher prevalence of other symptoms such as hyperlipidemia in men versus women. MetS describes a
constellation of risk factors, such as abdominal adiposity, hypertension, glucose intolerance/hyperglycemia,
and dyslipidemia, leading to diabetes and cardiovascular morbidity. High-caloric intake and sedentary lifestyle
habits are among key players shown to induce symptoms of MetS. However, exposures to environmental
chemicals such as persistent organic pollutants (POPs), often dictated by socio-economic status and
education levels, have been increasingly identified as additional key players leading to MetS consequences.
Previous studies showed that exposures to POPs, such as organochlorine pesticides (OCPs) and
polychlorinated biphenyls (PCBs), in in-vivo models and human studies were associated with diabetes, obesity
and non-alcoholic fatty liver disease, which are hallmarks for MetS development. Furthermore, using in-
vitro models and diet-induced obesity mouse models, we had previously demonstrated that the liver was
the predominant target organ of toxicity to POPs, including PCBs, and mechanism(s) of toxicity were
primarily through activation of hepatic receptors leading to metabolic disruption. The liver has long been
established as a sexually dimorphic organ and it is therefore important to address POPs toxicity in term of
biological differences or sex. Additionally, POPs such as OCPs are endocrine disrupting chemicals, having the
ability to interact with androgen or estrogen receptors, and potentially promoting variable effects in men and
women. However, most epidemiologic studies demonstrating associations between POPs exposure with liver
toxicity/metabolic diseases including diabetes either focused on agricultural workers who were mostly men or
adjusted for sex; but POPs exposures occur in both men and women and thus their health risks may vary.
POPs exposures today is primarily through ingestion of contaminated food and water, and serum levels can
vary depending on sex and gender. Hence, it is relevant to examine exposures to POPs such as OCPs based
on ‘environment-sex-gene’ interactions to better address such discrepancies.

Public health relevance
Project Narrative Mechanistic studies pertaining to sex-based differences in the metabolic syndrome are currently insufficient to explain and prevent the higher prevalence of certain metabolic conditions in women versus men and higher prevalence of other symptoms such as hyperlipidemia in men versus women. In addition, epidemiologic studies have reported that exposure to environmental chemicals such as persistent organic pollutants, including organochlorine pesticides, yield different health outcomes in men and women, and therefore, the current project aims to evaluate the underlying cellular mechanisms impacted by sexual dimorphism that potentially drive such differences. The concepts and information that will be gained from this grant will better address sex disparities in environmental health as well as provide health authorities with further knowledge to identify metabolic syndrome-related factors in susceptible populations and design sex-specific therapeutic strategies to better control future health care costs.